CANCER THERAPY EVALUATION PROGRAM INFORMATICS & COMPUTER SUPPORT

The objective of the Cancer Therapy Evaluation Program Informatics & Computer Support contract is to assist in achievement of the scientific goals of CTEP and the NCI while delivering operational efficiency to new and future business practices by designing, developing, implementing, and integrating innovative data collection systems, management tools, information storage, and communication systems. These tools, methods, and systems are termed the CTEP Enterprise System (CTEP-ESYS) and assist in the review, management, and conduct of oncology clinical trials and investigational agent development. The CTEP-ESYS contract is responsible for 1) providing a cost-effective approach to address administrative, scientific, and regulatory concerns; 2) providing reliable clinical results and toxicity data; enabling a shift in focus from administrative tasks to science for the scientists and physicians; 3) improving patient/trial safety; 4) ensuring the security and confidentiality of proprietary and patient information; 5) eliminating data redundancy throughout the oncology community; and 6) empowering personnel to make educated decisions by improving access to quality and timely data.